Core A: Administrative Core

ABSTRACT – CORE A: ADMINISTRATIVE CORE
The key functions of the Administrative Core (AC) are to: a) maximize the local, statewide and national impact
of initiatives developed and implemented by the Michigan ADRC; b) enhance collaborations across the three
partner universities comprising the consortium (University of Michigan, Wayne State University and Michigan
State University) and with the NACC, NCRAD and outside investigators; c) provide sound oversight for fiscal
and personnel matters; and d) ensure rigor, integrity and transparency in the research and activities supported
by the center. The AC’s stable leadership ensures that the various research, training and outreach initiatives
managed by the Cores will maintain synergy and connection to the Michigan ADRC’s central theme, which is
to identify, understand and modulate the myriad non-β-amyloid factors that contribute to brain dysfunction and
neurodegeneration in AD and related dementias. The AC will ensure a broadly supportive environment for all
investigators, but particularly for junior investigators, with the goal of nurturing a diverse group of next-
generation leaders. To have maximal effect as an ADRC, the AC will work closely with other centers and
programs across the consortium that are engaged in age-related research, including the six NIA-funded
centers that together comprise the UMAging Initiative. In six aims the AC will: 1) Leverage expert dementia
resources and skills focused in each Core; 2) Maintain cohesive interplay across the Cores; 3) Sustain existing
and build new local and regional partnerships; 4) Sustain existing and build further national partnerships; 5)
Promote efforts to address racial and ethnic disparities in ADRD; and 6) Develop next-generation leaders
through diverse research and training opportunities. In its first cycle as an NIH-designated ADRC, the Michigan
ADRC met its milestones due, in part, to a proactive AC that helped build key state-wide partnerships.
Benefitting from close links to the many complementary NIA-funded programs on our campuses, the
outstanding additional resources of all three universities, and continuing philanthropic success, the Michigan
ADRC is well-positioned to further enrich innovative dementia research, outreach, and training efforts, both
regionally and nationally.